Bitter taste receptors in oral cancer tumor-associated macrophages

PROJECT SUMMARY
Oral squamous cell carcinomas (OSCCs) are associated with poor prognosis and a 5-year mortality
rate of approximately 50%. These tumors are influenced by the cancer cells, tumor microenvironment, and
host immune system, with tumor-associated macrophages (TAMs) playing a pivotal role in shaping the immune
response and clinical outcomes. Macrophages exhibit diverse activation states, broadly categorized into pro-
inflammatory (M1) and anti-inflammatory (M2) subtypes, impacting tumor progression and metastasis.
Targeting macrophage pathways has emerged as a promising therapeutic approach for solid tumors, including
OSCC, but the underlying signaling pathways that mediate cancer and immune cell interactions are poorly
understood.
Our group previously identified bitter taste G protein-coupled receptors (T2Rs) as important sentinels of
immunity on immune cells such as macrophages where they enhance bacterial phagocytosis. We also found
that T2Rs are expressed on OSCC cells, where activation leads to apoptosis; furthermore, expression of some
T2Rs (including T2R4 and 14 genes/proteins) is associated with OSCC patient survival. We postulate that
T2Rs mediate essential interactions between OSCC cells and macrophages, presenting attractive therapeutic
targets to stimulate anti-cancer immunity. Our goal is to understand the involvement of T2R pathways in
OSCC-macrophage interactions and identify strategies to guide TAMs towards anti-tumor functions rather than
tumor-supportive phenotypes. Preliminary data suggests that activation of T2R4 and T2R14 in primary human
monocytes and macrophages enhances phagocytosis of OSCC cells.
We will further define T2R signaling mechanisms that regulate macrophage-mediated clearance
(efferocytosis) of apoptotic OSCC cells through T2R4 and 14 and downstream calcium and nitric oxide
signaling. To determine if T2Rs can be targeted/inhibited to guide macrophages phenotypes and support anti-
tumor behavior, we will also characterize the effects of T2R4 and 14 stimulation on macrophage polarization
(Aim 1). Live cell imaging and biochemical assays will be employed using primary human monocyte-derived
macrophages (from healthy donors and patients with OSCC) and patient-derived tumor slice cultures (TSCs).
Based on our previously published survival associations from The Cancer Genome Atlas, we hypothesize that
T2R signaling influences the pattern of TAM infiltration and oncologic outcomes. We will elucidate how
macrophage T2R expression/function affects TAM infiltration and clinical outcomes in human OSCC.
Additionally, murine studies will evaluate the effects of T2R agonist treatments on immune cell infiltrates and
tumor growth (Aim 2). Uncovering the intricate mechanisms of T2R-mediated interactions in OSCC and
macrophages will provide novel insights into therapeutic strategies for enhancing anti-cancer immunity.

Public health relevance
PROJECT NARRATIVE Bitter taste receptors are expressed in many locations of the body beyond the tongue, including in normal and cancerous tissues and on immune cells called macrophages. Macrophages, which combat infection and cancer, exhibit increased oral cancer cell clearance when bitter taste receptors are stimulated. Our goal is to understand the function of bitter taste receptors in tumor-associated macrophages so we can target them to fight oral cancer, ultimately improving outcomes for patients.